Development of Analysis Tools to Enhance Magnetomyographic Assessment of Pelvic Floor Muscles

Project Summary/Abstract
During pregnancy and delivery women experience pelvic soft tissue injury. This injury is associated with the
development of symptomatic pelvic floor disorders (PFDs) including pelvic organ prolapse, urinary, and fecal
incontinence. One of the biggest barriers to preventing birth injury and the subsequent sequelae of PFDs is our
lack of understanding of when and how injury occurs. Simulation models suggest that term delivery requires
stretch to the maternal pelvic floor musculature to a degree greater than that which skeletal muscle can normally
undergo without sustaining injury. Thus, with term vaginal birth, near universal injury would be expected.
Previous studies have used anatomic and functional methodology to explore this neuromuscular injury, but we
continue to lack a complete understanding of maternal pelvic floor injury and recovery patterns. We also possess
limited knowledge of the changes which maternal soft tissues undergo during pregnancy, presumably to facilitate
atraumatic birth. Our institution houses the SQUID Array for Reproductive Assessment (SARA) system, a novel
and noninvasive tool to assess biomagnetic signals such as those created by depolarization occurring with
muscle contraction. We propose to adapt SARA system to record the biomagnetic signals generated by the
levator ani muscles (LAMs) of the maternal pelvic floor and apply advanced signal processing techniques to
extract and characterize the LAM electrophysiology. These magnetomyographic (MMG) recordings will be used
to study maternal pelvic floor neuromuscular function before and after delivery. Our project will be the first to
comprehensively use MMG technology to assess the maternal LAMs. We will combine clinical, anatomic, and
physiologic endpoints to improve our knowledge of maternal pelvic muscular adaptations and injury recovery
patterns using a comprehensive protocol with which we have demonstrated promising preliminary data in small
cohorts of nulligravidas and nulliparous gravidas. This proposal is in response to NIBIB’s PAR-19-158
Bioengineering Research Grants, where we apply a multidisciplinary integrative team approach to address
the paucity of knowledge regarding maternal muscular adaptations and maternal LAM injury thus provide a
framework for future innovation in injury prevention and recovery research. Our overall hypothesis is that MMG
will allow detection of maternal LAMs adaptation during pregnancy and identification of injury and recovery
patterns postpartum. Aim 1: To adapt biomagnetic technology based system to record high spatial temporal
MMG LAM complex and apply advanced signal processing methods to extract relevant pelvic floor muscle
parameters. Aim 2: To track and characterize changes in levator MMG signals with parturition comparing 3rd
trimester pregnancy to early and late postpartum. Aim 3: To correlate MMG patterns of LAM birth injury and
recovery and associate MMG evidence of injury with PFD symtpoms and injury visible by transperineal US.

Public health relevance
Relevance Maternal birth injury clearly contributes to the development of pelvic floor disorders, yet we possess an incomplete understanding of the impact of maternal pelvic support adaptations, birth injury, and injury recovery on pelvic floor support. Using the novel approach of magnetomyography, our project will combine clinical, anatomic, and physiologic endpoints to improve our knowledge of maternal pelvic muscular adaptations and injury recovery patterns.